Microbiology Animal Food Track

PROJECT SUMMARY / ABSTRACT The Minnesota Department of Agriculture (MDA) Laboratory Services Division (LSD) is seeking funding under FDA funding opportunity PAR-20-105, “Laboratory Flexible Funding Model (U19)”. This summary is for the Microbiology Discipline Analytical Track 3: Animal Food Product Testing. The purpose of this track is to improve animal food testing surveillance programs through the microbiological analysis of animal food products. The test results generated can be used to remove adulterated animal food from commerce and aide regulatory inspection programs in conducting investigations. As part of this track the MDA microbiology lab commits to analyzing at least 500 animal food product samples. Project Summary/Abstract - Minnesota Department of Agriculture